ELSIhub: National Center for ELSI Resources and Analysis

The Center for ELSI Resources and Analysis (CERA) was established in 2019 to develop a platform for dissemination, sharing, curation, and synthesis of ELSI research products (ELSIhub) and to convene a broad base of ELSI-interested communities to support the development of CERA resources. Building on over four years of experience and relationship-building with ELSI-relevant communities, and the knowledge-to-action (KTA) framework, we will develop processes for content development and facilitate collaboration to enhance the dissemination, uptake, and translation of ELSI research. CERA | ELSIhub will be guided by the principles of responsiveness, adaptability, engagement, rigor, transparency, and open access. Our specific aims are to:
Aim 1: Develop and maintain the ELSIhub platform for researchers to share and search for ELSI research products
Aim 2: Curate and synthesize ELSI research
Aim 3: Facilitate new collaborations and increase uptake of ELSI research
Over the past four years, we have established a solid foundation for interdisciplinary collaboration and resource development, focusing on the ELSI research community. We also conducted a comprehensive accessibility assessment of ELSIhub and CERA events and implemented a plan to broaden accessibility and develop best practices for accessibility for the ELSI research community. In the next award period, CERA will expand its focus on ELSI researchers by establishing new collaborations with genome scientists, ELSI scholars and trainees to promote interdisciplinary work in and between ELSI research and ELSI-adjacent fields of study. We will introduce the ELSIconnect program and ELSI Journal Clubs to encourage collaboration and resource sharing among a wide range of ELSI-interested groups and to crowdsource identification of high priority areas for CERA events and resources. We will explore innovative methods to assess the feasibility of responsible and valid AI-assisted curation and synthesis of ELSI research, using large language models trained on ELSI research products drawn from ELSIhub databases. We will also add an independent Evaluation Team to design and conduct program evaluation and analyze platform use.

Public health relevance
The goals of the Center for ELSI Resources and Analysis (CERA), and its web portal ELSIhub, are to serve as a locus for resource sharing and community building to enhance the production, sharing, and use of research on the ethical, legal, and social implications of genetics and genomics (ELSI research).